Core-001

UMCCTS Informatics has advanced clinical and translational research and workforce development by providing access to biomedical data and user-friendly informatics tools. In close collaboration with other UMCCTS Cores and UMass computer science departments, we have developed and implemented informatics tools and processes to manage research operations and to securely collect, extract (from EHR and other sources), share, analyze, and store data. With a strong foundation in data and systems, we are now poised to expand data driven research and care in the next funding cycle, through the following Specific Aims: (1) Expand access to data and analytics to support high-impact research; (2) Develop and promote full utilization of a robust, secure, and easy-to-use research informatics framework that fully integrates with EHR; and (3) Advance innovative informatics approaches and lead the development of a data- and informatics-savvy workforce.

Public health relevance
UMCCTS Informatics is the nucleus and driver for biomedical data access, analytics, and informatics tools across our 5 UMass campuses and clinical partners. Our mission is to enable high-quality, reproducible preclinical, clinical and translational research (CTR) that addresses unmet health and healthcare needs swiftly, efficiently, and robustly. In close collaboration with other UMCCTS Cores and UMass computer science departments, we advance innovative informatics approaches, support researchers across the entire CTR spectrum, and build an informatics-savvy biomedical workforce.